IGF::OT::IGF - OTHER FUNCTIONS/TASK ORDER ON WESTAT CONTRACT ARP FUNDED; TASK ORDER FOR UNDERSTANDING CANCER PATIENT EXPERIENCES AND CARE WITH PROMIS

Understanding cancer patient experiences and care with PROMIS; examination of demographic and clinical characteristics associated with outcomes in a large sample of cancer patients.